Mosaic loss of Y chromosome in blood and heart failure

PROJECT SUMMARY/ABSTRACT
Recent technological advances indicate that somatic DNA mutations accumulate with age and that they are
remarkably prevalent. Mosaic loss of the Y chromosome (mLOY) in blood is the most common post-zygotic
mutation in humans. Epidemiological studies have associated mLOY with all-cause mortality and multiple of age-
associated diseases. However, it is unknown whether there is a causal connection between mLOY and disease.
The parental grant is employing murine models to assess the impact of mLOY in heart failure at a mechanistic
level. The Administrative Supplement will build upon the concepts and technology developed with the parent
grant to explore the causal role of mLOY in cognitive decline and define aspects of mechanism.
Epidemiological studies have associated mLOY in blood with Alzheimer’s Disease and Related Dementias
(ADRD). However, no work has addressed whether mLOY is mechanistically linked to cognitive decline. To
address this gap in knowledge, we request a one-year administrative supplement to perform exploratory
analyses of experimental mLOY in the Bilateral Carotid Artery Stenosis (BCAS) model of Vascular Contributions
to Cognitive Impairment and Dementia (VCID). The BCAS model gives rise to cerebral hypoperfusion and leads
to white matter damage, neurodegeneration and consequent cognitive decline. The rationale for the BCAS study
is: 1) mLOY is associated with cerebrovascular pathologies closely associated with VCID, including transient
ischemic attacks, occlusion and stenosis of pre-cerebral arteries and cerebral infarction, and 2) the BCAS model
has relatively rapid turnaround that is suitable for this one-year supplement. We anticipate that the new research
funded by the Administrative Supplement will extend our pilot data showing that aging mLOY mice (15 months
after BMT) had short-term working memory deficits in the Y-maze and novel object recognition tests. Thus, in
the proposed studies, we will 1) investigate whether mLOY promotes cognitive decline in the BCAS model of
VCID using multiple independent models of mLOY, and 2) investigate whether impaired clearance of senescent
cells by mLOY immune cells contributes to cognitive decline.

Public health relevance
PROJECT NARRATIVE Loss of the Y chromosome in the blood of males increases with age, and it is associated with diminished survival and an increased risk of various diseases. However, it is not known if the loss of the Y chromosome has a causal role in age-associated diseases or whether it is an epiphenomenon of biological aging processes. In the Administrative Supplement, we will employ novel mouse models to test whether the loss of the Y chromosome in blood cells impacts cognitive decline.